Leveraging Ecological Momentary Assessment to Examine Peer Affiliations as a Mechanism of Behavior Change in Youth Alcohol Use Treatment

PROJECT SUMMARY/ABSTRACT
BACKGROUND. Alcohol use (AU) and misuse, including the onset of alcohol use disorder (AUD), peak during
adolescence and emerging adulthood. Despite the adverse effects of AU among youth, such as increased risk
for the development of substance use disorders and increased risk of alcohol-related deaths, the best available
psychosocial interventions for AUD yield only modest short term benefits among youth. One way to improve
treatments for AUD and reduce the public health burden associated with youth AU is to advance our
understanding of how interventions work. Virtually all evidence-based psychosocial interventions emphasize
shifting from alcohol using peers to non-using peers because youth AU predominantly occurs in the presence
of peers, and affiliating with AU using peers is consistently associated with increased risk for relapse and
worse treatment outcomes. To date, AUD treatment research has largely neglected the peer context of
adolescents and emerging adults and this is particularly concerning because failure to consider the centrality of
peer relationships in adolescent AU interventions leads to diminished and, in some cases, iatrogenic effects.
SPECIFIC AIMS. This F32 supports the first study, to our knowledge, to use ecological momentary
assessment (EMA) to examine whether daily level shifts from alcohol using to non-using peers over the course
of AUD treatment leads to reductions in drinking and identify when these shifts occur. METHODS. Using an
existing data set of a clinical trial examining the effects of medication (topiramate) and motivational
enhancement and cognitive behavioral therapies (MET-CBT) relative to placebo plus MET-CBT using EMA (N
=82; ages 14-24 years), the project will examine 1) the amount of time youth spend with alcohol-using and
non-using peers from pre to post intervention in topiramate and placebo conditions, 2) whether topiramate
leads to reductions in AU by attenuating the relationship between being in the presence of alcohol using peers
and subsequent AU, and 3) whether lower levels of alcohol use, resulting from the attenuated relationship
between being in the presence of alcohol-using peers and subsequent AU in the topiramate condition, in turn,
leads to greater time spent with non-alcohol using peers. LONG-TERM GOAL. This research plan provides the
opportunity for mentored training in identifying mechanisms of behavior change for youth AUD treatments and
advanced training in collecting and analyzing complex EMA data. The identified mentorship team includes
experts in the fields of adolescent addiction treatment, mechanisms of behavior change research, clinical trials
research, and EMA data collection and analysis., and is housed in internationally recognized clinical and
addiction research centers. The current F32 project will facilitate a successful transition to research
independence and will support future grant applications that will investigate how social and biological
processes impact AUD treatment leveraging EMA designs. Thus, this F32 aids the NIAAA's research priorities
of identifying mechanisms of action for pharmacotherapy and reducing youth AU.

Public health relevance
PROJECT NARRATIVE Understanding mechanisms of behavior change is critical to refining and improving alcohol use disorder interventions for youth, which consistently demonstrate weaker effects than adult interventions and yield only modest short term benefits. Considering affiliations with alcohol using peers is associated with increased risk for relapse and worse treatment outcomes, nearly all alcohol use disorder psychosocial interventions emphasize shifting from alcohol using to non-alcohol using social networks as a critical mechanism of change. Examining when and how this shift occurs in peer relationships for youth in treatment for alcohol use disorder will provide critical information to strengthen alcohol use disorder interventions for youth and support clinicians working with this population.